Myocyte-to-kidney Signaling in Cardiorenal Nephrosclerosis and Hypertension

Acute cardiorenal syndrome (cardiorenal syndrome type 1, CRS1) frequently follows the most common cause
of admission to a Veterans Health Administration inpatient facility, acute cardiovascular disease. Although
CRS1 seems to self-resolve in most cases, development of chronic kidney disease often occurs rapidly
afterward (within 1-2 years). Animal studies demonstrate there is mechanistic connection between CRS1 and
early onset CKD, a form of AKI-CKD transition. The long term goal is to determine mechanisms of long-term
outcomes of CRS1 with a focus on the potential for translational intervention. The proposed work is focused
on whether and how CRS1 induces further cardiovascular disease commonly comorbid with CKD. Published
data generated in a mouse model of CRS1, cardiac arrest and cardiopulmonary resuscitation (CA/CPR)
demonstrate that despite recovery of renal function 2 weeks after CA/CPR, CKD ubiquitously occurs by 7
weeks after CA/CPR. Data generated for this proposal show that 7 weeks after CA/CPR, mice have
developed systemic hypertension with associated changes in renal vascular architecture and myocardial wall
thickness. Tantalizingly, CKD and systemic hypertension are recapitulated by injection of a soluble cardiac-
derived factor, CSRP3, which is released into the plasma after CA/CPR. CSRP3 functions as transcriptional
activator of the myogenesis pathway in cardiac development. Data suggest that CSRP3 mediates the renin-
angiotensin system through angiotensin-converting enzyme 2 (ACE2) in the renal proximal tubule. Therefore
the central hypothesis in this proposal is acute cardiorenal syndrome causes chronic systemic hypertension via
CSRP3-induced, myogenesis-mediated reduction of proximal tubule ACE2 activity. The specific hypothesis is
that that the myogenesis factor MyoD is induced in proximal tubule epithelial cells by CSRP3 exposure, and in
turn represses ACE2 membrane distribution. This hypothesis will be investigated in two specific aims. Aim 1
will determine the mechanism by which CRS1 causes chronic systemic hypertension in vivo. Wild-type mice,
and mice with inducible, cardiac-specific deletion of CSRP3, or deletion of proximal tubule ACE2 will be
subjected to CA/CPR. It is hypothesized that in the absence of cardiac CSRP3, hypertension will be blunted,
while in the absence of ACE2 in the proximal tubule, hypertension will be exacerbated. Blood pressure will be
assessed in awake, unrestrained mice 7 weeks after CA/CPR using radiotelemetry, and renal function,
myogenesis determination genes, and components of the renin-angiotensin system including ACE2 will be
assessed using qPCR, immunoblotting, and renal immunofluorescence. Heart and kidney sections will be
assessed to determine whether myocardial wall thickness and renal arcuate arterial wall thickness are altered.
Translational experiments will determine plasma CSRP3 levels in deidentified patients with cardiac disease,
and test whether pharmacologic inhibition of CSRP3 uptake in the kidney ameliorates development of
hypertension in mice. Aim 2 will delineate the mechanism of proximal tubule epithelial cell functional change in
vitro, and will be performed in primary culture of human proximal tubule epithelial cells. To test the hypothesis
that CSRP3 induces proximal tubule epithelial cell functional change including reduction of ACE2 polarity via
regulation of myogenesis determination genes, cells will be exposed to recombinant CSRP3, vehicle, and
relevant protein controls. To model the inflammatory environment in the AKI-CKD kidney, transforming growth
factor beta will be used to costimulate cells in addition to CSRP3 alone. qPCR, immunofluorescence, and
immunoblotting will be used to assess ACE2, myogenesis determination gene transcripts, expression, and
distribution. Effects on ACE2 polarity and function will be evaluated. shRNA interference will be used to knock
down expression of critical pathway mediators including myogenic differentiation antigen (MyoD). The studies
proposed here test mechanisms of interaction between the injured heart and kidney, and will delineate an
important pathway by which CRS1 leads to chronic cardiorenal disease.

Public health relevance
The most common cause of hospitalization for Veterans, acute cardiovascular disease, commonly injures the kidneys, and can cause long-term chronic kidney disease. Chronic kidney disease in turn is closely associated with worsening of cardiovascular disease, particularly high blood pressure. The current study will evaluate the development of new high blood pressure in a model of acute cardiovascular disease, which is very similar to the human clinical condition. We propose a mechanism in which a factor released by the heart changes kidney function, causing high blood pressure; this mechanism is potentially interruptible with drug therapy. Successful completion of this project is therefore expected to evaluate a new potential means for the heart and kidney to interact in causing disease which is highly relevant to Veteran and public health.